Microbial Genomics and Analytical Laboratory (M-GAL)

Project Summary – CORE C: Microbial Genomics and Analytical Laboratory (M-GAL)
The Microbial Genomics and Analytical Laboratory (M-GAL) Core of the Integrative Center for Environmental
Microbiomes and Human Health will provide a centralized facility and technical expertise at the University of
Hawai`i at Mānoa (UHM) to support the study of the interface between the microbial environment and human
health. The characterization of microbial community composition by next-generation sequencing and analysis
of microbial metabolic products are standard methods used in the field of microbiome research. To enable
these applications, the M-GAL Core will provide the following: (i) equipment and expertise for the preparation
of genomic libraries and the quantitation of gene expression; (ii) high-performance liquid chromatography and
mass spectrometry instrumentation for the analysis of lipids and metabolites; (iii) facilities for the cultivation,
isolation, and long-term storage of microbial strains; and (iv) curation of a community searchable database
containing information about strains isolated from native Hawaiian fauna and ecosystems. The M-GAL core
will be available to researchers throughout the state of Hawai'i and visiting scientists, thus encouraging greater
interaction amongst the local microbiome research community and seeding collaborative efforts from abroad.
The M-GAL Core will beneficially impact COBRE investigators and affiliates by providing essential
infrastructure and expertise to advance their research and foster the careers of junior faculty. Moreover, the
Core will support the growth of UHM as a major center for microbiome studies in the Pacific Region by
providing hands-on training in library preparation and metabolite analysis, hosting an international summer
school on fundamental microbiome research methods, and facilitating outreach efforts to characterize
Hawai'i's microbiome.
!